COMMUNITY CLINICAL ONCOLOGY PROGRAM

The Florida Pediatric Community Clinical Oncology Program is a consortium of four Florida hospitals (All Children's Hospital, Jacksonville Wolfson Children's Hospital, Orlando Regional Medical Center, and Sacred Heart Children's Hospital) which seeks to affiliate with the Pediatric Oncology Group as its research base. These four hospitals complement the three major university teaching hospitals which are also Pediatric Oncology Group members and, in total, comprise the Florida Association of Pediatric Tumor Programs. The goal of the Florida Pediatric CCOP is to make available the latest advances in cancer care to patients in Florida through participation in clinical trials. The CCOP participants will utilize an existing Statewide Patient Information Reporting System as a log of all patients seen in the state. Patients will be registered on POG protocols through the POG Statistical Office which is co-located with the Central Office of the Florida Pediatric CCOP. This unique arrangement affords the opportunity to ensure that the majority of eligible patients are registered on appropriate POG protocols. An excess of 45 patient registrations are anticipated per year through the four hospitals which comprise the Florida Pediatric CCOP. POG quality control procedures will be extended to include the Florida CCOP, ensuring compliance with protocols and external review of pathology, radiotherapy, surgery, and chemotherapy. The Florida Pediatric CCOP extends the latest treatment advances through the opportunity to participate in clinical trials to a significant segment of the Florida population.